Evaluating Practice Facilitation to Optimize Alcohol-Related Care and HCV Treatment Outcomes in HCV Treatment Settings

Background. Hepatitis C virus (HCV) is among the most common chronic viral infections in the U.S. and has
surpassed all other infectious diseases as a cause of death. With the arrival of highly efficacious directly-acting
anti-viral agents, treatment for HCV is now curative for the vast majority of patients. The VA is the largest
provider of HCV care in the world and has scaled up efforts to identify and treat HCV. Unhealthy alcohol use is
very risky for patients with HCV and influences HCV treatment adherence and outcomes. Despite the risks
associated, many patients with HCV drink alcohol at unhealthy levels. While alcohol use was previously a
contraindication to treatment, VA guidelines now recommend consideration of treatment for all patients with
HCV, including those with unhealthy alcohol use, creating a prime opportunity for co-interventions focused on
addressing unhealthy alcohol use during HCV treatment. HCV treatment-typically delivered over multiple visits-
may provide time-limited opportunities for delivery of evidence-based alcohol-related interventions, but, due to
previous contraindications, clinicians in HCV treatment settings are likely unprepared to offer evidence-based
alcohol-related care. Practice facilitation is an effective multilevel implementation strategy that has promise for
facilitating provision of alcohol-related care and ultimately improving alcohol use and HCV outcomes among
patients with HCV and unhealthy alcohol use.
Objective. The proposed study—conducted by a unique team of experts in implementation science and HCV
and alcohol-related care—will use practice facilitation to increase provision of evidence-based alcohol-related
care in HCV treatment settings and improve alcohol use and HCV treatment outcomes among Veterans with
HCV and unhealthy alcohol use.
Methods. The study will be guided by the Consolidated Framework for Implementation Research (CFIR)
model. In Aim 1, we will use semi-structured qualitative interviewers with key clinical and patient stakeholders
and rapid analytic methods to tailor the practice facilitation intervention. In Aims 2 and 3 we will disseminate
the tailored intervention to 4 VA clinics in the western U.S. and then apply a Hybrid Type III implementation/
effectiveness design to evaluate the influence of the tailored practice facilitation intervention on implementation
(primary) and clinical effectiveness (secondary) outcomes. Five implementation outcomes (acceptability,
feasibility, adoption, penetration, and fidelity of alcohol-related care) and three clinical outcomes (alcohol use,
HCV treatment completion, and sustained virologic response) will be evaluated using mixed methods. The
primary implementation outcome (penetration) and clinical outcomes, will be evaluated using an interrupted
time series design in which the implementation intervention is rolled-out in a stepped wedge fashion and clinics
serve as their own controls (pre-post). Order in which the clinics receive the intervention will be randomized.
Impact. The study is aligned with VA’s cross-cutting research priorities focused on mental and behavioral
health, healthcare access, implementation science, and health disparities and with VA’s commitment to
providing patient-centered care for unhealthy alcohol use. If effective, the implementation intervention could be
scaled throughout VA HCV treatment settings, which could improve health among the vulnerable population of
Veterans with HCV and unhealthy alcohol use and may optimize return on VA’s large investment in HCV
treatment via reductions in treatment discontinuation and increased cure rates. Moreover, the intervention will
help clinicians in VA liver clinics offer alcohol-related care to patients with chronic liver conditions influenced by
alcohol use even as the demand for HCV treatment decreases.

Public health relevance
Hepatitis C virus (HCV) is among the most common chronic viral infections in the U.S., and has surpassed all other infectious diseases as a cause of death. Unhealthy alcohol use is very risky for but common among patients with HCV. VA has increased access to treatment for patients with HCV, including requiring that all patients with HCV be considered for HCV treatment regardless of alcohol use. Yet heavy alcohol use could impact adherence, response, and subsequent liver outcomes. This creates a prime opportunity for offering evidence-based care for unhealthy alcohol use concurrent with HCV treatment. This study will tailor and test a practice facilitation implementation intervention to increase access to evidence-based alcohol-related care during HCV treatment. If effective, this intervention has potential to optimize Veterans’ health by reversing the devastating impact of alcohol use on HCV outcomes and will lay a foundation for clinicians in liver clinics to address alcohol use among patients with other chronic liver conditions adversely impacted by alcohol use.